IMPROVING THE RESOLUTION OF THE STRUCTURE OF THE NUCLEAR PORE COMPLEX

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are using various techniques to attempt to further improve upon our structure of the nuclear pore complex (F.Alber, S. Dokudovskaya, L.M. Veenhoff, W. Zhang, J. Kipper, D. Devos, A. Suprapto, O. Karni-Schmidt, R. Williams, B.T. Chait, M.P. Rout, Andrej Sali The molecular architecture of the nuclear pore complex Nature 450 (2007) 695-701).